Neuro-Oncology Program

ABSTRACT – NEURO-ONCOLOGY PROGRAM
According to data published by the National Cancer Institute in 2014, there were an estimated 162,341
people living with brain and other nervous system cancer in the United States. Malignant primary brain tumors
are the most frequent cause of cancer death in children and young adults and account for more deaths than
cancer of the kidney or melanoma.
The Neuro-Oncology Program is one of the most well-known and oldest cancer programs at Duke, having
celebrated its 80th anniversary in 2017. The first to establish brain tumor research and clinical activities at Duke
was Dr. Barnes Woodhall, who came to Duke from Johns Hopkins in 1937. The Neuro-Oncology Program has
been a premier program within the DCI since its initial designation as an NCI Comprehensive Cancer Center in
1972.
Research ranges from the most basic science to clinical trials encompassing various focus areas including
basic and functional genomics; establishment of a world class biorepository including more than 4000 adult and
pediatric brain tumor samples, more than 80 xenografts and transgenic models to recapitulate human disease
and for drug/agent screening; development of novel immunotherapies for primary and metastatic CNS tumors;
design and execution of Phase I, II, and III clinical trials; improving patient’s quality of life and treatment
experience through Supportive Care clinical trials; and molecular epidemiology and genomic studies to identify
causation factors of malignant brain tumors. This research is driven by the Neuro-Oncology Program’s mission
to identify the cause and relevant tumor biomarkers in all major types of adult and childhood malignant brain
tumors and to invent and translate novel therapeutics from screening in innovative and predictive model systems
to human testing and development in pioneering clinical trials. Maintenance of the comprehensive tumor
biorepository and training of the next generation of neuro-oncologists ensures the continuing development of the
Neuro-Oncology Program and its research goals.
The Program is comprised of 27 primary members and 6 secondary members from a wide spectrum of 8
different departments and 1 school and institutes within Duke University. Total direct funding for primary
Program members is $11.9M of which $6.1M is peer reviewed, including $3.7M from the NCI. From 2014-2018,
Program members published 415 papers in peer-reviewed journals cited in PubMed. Of these publications, 33%
are the result of intra-programmatic collaborations and 36% are due to inter-programmatic collaborations. During
the current grant period, the program enrolled 948 subjects to all trials, 736 to interventional trials, and 551 to
treatment trials.